Targeted Circuit Manipulation for Ameliorating Huntington's Disease Pathogenesis

PROJECT SUMMARY/ABSTRACT
The Diversity Supplement candidate will be trained in all aspects of manipulating the firing activity within the
cortico-striatal microcircuit by chemogenetic inhibition of pyramidal neurons, testing efficacy of inhibition by
electrophysiological recordings in vivo, and assessing in behavioral tests if these manipulations before the onset
of symptoms will slow HD disease progression. The training includes stereotaxic injections of AAV, acute
extracellular recordings and computational electrophysiological data analysis, and conducting behavioral test
batteries and analyzing the collected data. The experimental approach will allow the candidate to assess the
efficacy of novel inhibitory luminopsins within this well-defined experimental paradigm while building a solid
conceptual and experimental foundation for his future activities in biomedical research.
The training experiences the candidate will gain are critical for his understanding and interpretation of state-of-
the-art neuroscience experiments. The training plan takes into consideration that the candidate is at the very
beginning of his research training and ensures that the candidate will have an exceedingly strong background
for entering the next phase of research training towards meeting his career goals. His training will have ranged
from hands-on experience in executing in vivo experiments for controlling neural activity and behavior to
evaluating and interpreting the collected data. Therefore, this training in in vivo electrophysiology and behavior
testing will not only significantly contribute to the parent grant but will specifically provide him the experience
required to pursue his long-term interest in pursuing a career as a physician-scientist.
The proposed training outlined in the application is ideal given the candidate’s career stage and future plans and
is tailored to having the greatest impact within th ehsortest possible time. An established training strategy will
foster the candidate’s ability to swiftly reach a level where he can independently approach new projects and will
be an asset to any research lab where he continues his training.
The proposed supplement activities will increase the parent award’s overall impact within the original scope of
award while at the same time advancing the training and career development of the candidate.

Public health relevance
PROJECT NARRATIVE The BRAIN initiative has enabled the development of approaches for modulating specific microcircuits through genetically targeting discrete types of neurons; however, their application to disease models is lagging. In this collaboration between Huntington’s disease (HD) researchers and BRAIN tool developers we will utilize novel interventional tools for changing neural circuit dynamics at the early, pre-symptomatic stage for preventing or delaying and mitigating the behavioral deficits in a transgenic mouse model of HD. Our project will drive translational progress toward potential novel therapeutic purposes for HD as well as other neurodegenerative diseases that show circuit imbalances, while at the same time addressing basic questions of neural circuit function underlying behavior relevant to both NINDS and NIMH.